Mechanosensor Function in the Control of Gas Exchange Surface Size and Composition

PROJECT SUMMARY/ABSTRACT
With each inhalation, exhalation and across development, maturation, aging and
pathogenesis, the lung is constantly under mechanical tension. How the biophysical force is
sensed and responded to remains poorly understood. In the gas exchange region that bears the
front of this force, tension is distributed across the vast alveolar surface. In this study, we will
investigate the central premise that mechanical tension, sensed by alveolar epithelial cells,
triggers a molecular feedback loop that drives the generation and regeneration of the gas
exchange surface area.
At the center of this feedback loop is Piezo, a large membrane localized channel that is a
quintessential mechanosensor. First discovered and studied in neurons, Piezo genes are also
widely expressed in the lung. Our preliminary data show that while loss of Piezo genes in the
lung mesenchyme or the endothelium did not lead to discernable alveolar structural defects,
inactivating these genes, especially Piezo2, in the lung epithelium led to alveolar simplification
in the early postnatal lung. In the adult lung, Piezo2 loss in the alveolar epithelium led to
drastically increased susceptibility to alveolar damage, leading to fibrosis. In this study, we will
investigate the nature of this mechanosensory circuit in development (Aim 1) and injury repair
(Aim 2). The findings will advance our knowledge on how mechanosensation could tune the size
and composition of the alveolar surface.

Public health relevance
NARRATIVE With each breath and across the lifespan in health and disease, the lung is under dynamic changes of mechanical force. How this force is sensed and translated into molecular cues that impact lung formation, injury repair and function is poorly understood. In this study, we will investigate the role of the cardinal mechanosensor PIEZO channels at the center a molecular feedback mechanism that controls gas exchange niche size and composition during the construction and reconstruction of the lung.